Project STRIVE (STudents RIsing above) - Offsetting the health and mental health costs of resilience

PROJECT SUMMARY
Students in marginalized communities who ‘strive’ to rise above adversity to achieve academic success
are considered ‘resilient’. However, youths’ resilience in one domain (i.e. academic) can come at a cost in
other domains including physical and mental health morbidities that are under-identified and under-treated.
Previous research suggests that racial ethnic minorities who exhibit a “striving persistent behavioral style” in
the face of adversity evince later health morbidities. Ironically, the same self-regulatory skills that promote
academic achievement amid chronic stress can also result in physiological dysregulation that harms health and
mental health1–3. Self-regulatory processes that involve emotion suppression, experiential avoidance, and
unmodulated perseverance can culminate in allostatic load which fuels health disparities1,4 and internalizing
symptoms of depression and anxiety5.
This mechanistic trial uses mindfulness training to permit examination of questions about the causal role
of emotion regulation strategies linked to the striving persistent behavioral style in driving mental health and
health morbidities among high achieving youth78. The proposed Project STRIVE (STudents RIsing aboVE) will
identify students who are academically resilient in the face of disadvantage and will offer a tailored mindfulness
intervention targeting self-regulation processes as a putative mechanism to interrupt the links between the
striving persistent behavioral style and negative health outcomes. We propose a multisite randomized trial
randomizing 504 high achieving, socioeconomically disadvantaged Black, Latine and Asian American students
in 18 schools to receive a mindfulness intervention or an attention control condition focused on study skills.
The study will: (1) test the effects of the STRIVE intervention on putative self-regulation mechanisms (emotion
suppression, experiential avoidance, and unmodulated perseverance) among. (2) test the effects of the
STRIVE intervention on health and mental health outcomes at 12-month post-treatment, including biomarkers
of allostatic load (cortisol, blood pressure, body-mass-index, waist/hip/neck circumference), health complaints,
and internalizing symptoms, and (3) examine the mechanistic model linking striving persistent behavioral style
and health outcomes within the STRIVE trial. If successful, this trial will build toward a scalable, secondary
preventive intervention with potential for preventing both health and mental health disparities among
underserved youth at the population-level.

Public health relevance
PROJECT NARRATIVE The proposed mechanistic trial will utilize mindfulness training to permit examination of questions about the causal role of emotion regulation strategies linked to the striving persistent behavioral style in driving mental health and health morbidities among socially mobile youth78. The proposed Project STRIVE (STudents RIsing aboVE) will identify students who are academically resilient in the face of disadvantage and will offer a tailored mindfulness intervention targeting self-regulation processes as a putative mechanism to interrupt the links between the striving persistent behavioral style and negative health outcomes. We propose a multisite randomized trial to the effects of the STRIVE intervention on putative self-regulation mechanisms, health and mental health outcomes, and to examine the mechanistic model linking striving persistent behavioral style to health and mental health morbidities.